Contact System and Alzheimer's Disease: Mechanism and Therapeutic Potential

PROJECT SUMMARY
Alzheimer's disease (AD) is a complex, multifactorial disease that leads to profound
neurodegeneration, cognitive decline, and eventually death. There is strong evidence that the
Alzheimer's beta-amyloid peptide (Aβ) is an important driver of the disease. However, the
mechanisms by which Aβ is toxic are not defined.
There is increasing evidence that inflammation and vascular abnormalities contribute to AD
pathology. One pathway that links these two processes is the plasma contact system. We have
found that this system can be initiated by Aβ and is activated in AD plasma from human patients
and mouse models. Furthermore, inhibition of the contact system in AD mice improves their
pathology and cognition.
We propose to further define how the contact system and its components, specifically high
molecular weight kininogen (HK) and coagulation factor XII (FXII), contribute to AD
pathophysiology. We have found that Aβ protofibrils are the most effective Aβ species to
activate the contact system. Aβ protofibrils are also the main target of lecanemab, the promising
new FDA-approved antibody therapy for AD patients. We will investigate how lecanemab might
interfere with the contact system to generate its beneficial effects in humans and determine if
both lecanemab and a contact system inhibitor could have a synergistic effect on AD pathology.
We will also study the structural interaction between Aβ protofibrils, HK, and FXII to determine
mechanistically how Aβ causes contact system dysfunction in AD. Finally, we will explore the
potential of an anti-HK antibody as a new therapeutic avenue for AD.

Public health relevance
PROJECT NARRATIVE We have shown that the plasma contact system, which regulates both blood clotting and inflammation, is dysfunctional in human patients and mouse models of Alzheimer's disease (AD), a fatal neurodegenerative disorder. We will use various pharmacological and biochemical techniques to define the contribution of this system in AD pathogenesis. We will also examine the potential of inhibiting the contact system as a therapeutic target for AD and explore the mechanism-of-action of lecanemab, a new and promising FDA-approved therapy for AD.